Commumity Liaison and Recruitment Core

ABSTRACT: COMMUNITY LIAISON AND RECRUITMENT CORE
The Community Liaison and Recruitment Core (CLRC) serves as a liaison between the Michigan Center for
Contextual Factors in Alzheimer’s Disease (MCCFAD) and key stakeholders in the metro-Detroit Middle
Eastern and North African (MENA) community and the Grand Rapids Latino community. We propose three
major ways to extend MCCFAD’s work in recruitment, retention science, and community translation. First, we
will expand our engagement efforts by linking our recruitment and community research activities with key NIA
funded Michigan Aging Centers. Second, we will actively solicit community engagement in scientific
dissemination. Third, we will expand our liaison activities to partner with community clinics, health providers
and public health workers to enhance participation in research. To support MCCFAD goals of advancing
research and practice in Alzheimer’s disease and related dementias, the CLRC leads the development,
implementation and evaluation of an adapted innovative Community Based Participation Research approach to
health education and community outreach activities, with an overarching goal of enhancing research in
recruitment and retention. These efforts will be closely coordinated with the activities of the Leadership and
Administrative, Research and Education and Analytic Cores in addition to the Michigan Center for Urban
African American Aging Research (MCUAAAR) and the Michigan Alzheimer’s Disease Research Center
(MADRC). Both MCUAAAR and MADRC have established community cores comprised of African Americans.
MCCFAD will focus efforts on further building their Research Volunteer Directory (RVD) in the MENA and
Latino communities. The RVD will support research that aims to: 1) reduce risk of developing ADRD, 2)
promote culturally sensitive care, and 3) address the health economics of ADRD. Community partnerships in
metro Detroit and Grand Rapids enhance the reach and depth of CLRC activities. CLRC specific aims address
the following: Aim 1: Enhance outreach, recruitment and retention of Middle Eastern and North African (MENA)
and Latino communities to foster inclusion and active participation in ADRD research; Aim 2: Disseminate
scientific knowledge of techniques for recruiting and retaining diverse and population-representative research
participants; Aim 3: Develop culturally tailored educational materials to provide the MENA and Latino
communities with feedback on research advances and to inform their engagement with the healthcare system.
The CLRC will continue to advance knowledge about factors affecting research participation of underserved
and underrepresented communities in ADRD research. By engaging each community in an equitable
partnership and incorporating links with health professionals, we aim to advance scholarship on ADRD among
hard-to-reach populations to promote sustained change around relevant to ADRDs disparities.